Membrane Micropeptides and Calcium Pump Allostery

Project Summary/Abstract: The lead investigator, Seth Robia, and co-PI Gianluigi Veglia, share a
mutual interest in SERCA regulation and have a track record of successful collaboration utilizing
complementary approaches. Our prior collaboration received support from an NIH multi-PI R01, and
this current proposal seeks to renew that grant. The proposed project aims to determine the influence
of membrane micropeptides on the allosteric regulation of the SERCA Ca pump. These small proteins
are expressed differently in various tissues, and each has a distinct way of regulating SERCA, but the
structural determinants that contribute to these regulatory characteristics are still unknown. Our
approach will involve using a combination of fluorescence methods and NMR spectroscopy to
investigate the structure of the micropeptide/SERCA protein complex and dynamic protein-protein
interactions. Subsequently, we will analyze how various micropeptides modulate SERCA function to
govern cardiac contraction and relaxation. The planned experiments will uncover how SERCA activity
is finely tuned in the healthy heart, enabling it to adapt to exercise or other physiological stressors.
Additionally, we aim to uncover the pathogenic mechanisms associated with genetic variants that
disrupt micropeptide regulatory processes, ultimately leading to heart failure.
The research plan comprises two major aims. Aim 1 will identify unique determinants of function and
more general features that are shared across different members of the membrane micropeptide
family. In Aim 1a, we will determine how micropeptides modulate allosteric pathways of
communication within the structure of the Ca pump. We hypothesize that micropeptides tune cellular
calcium handling by modulating the pathway of communication between ATP- and Ca-binding sites
on SERCA. Aim 1b will test our specific hypothesis that the tilt angle of the transmembrane domain
dictates micropeptide inhibitory potency. Aim 2 is focused on mechanisms of heart failure. Aim 2a will
examine the binding dynamics of the prototypical micropeptide phospholamban. We will measure
how these interactions are changed by genetic variants associated with dilated cardiomyopathy. We
hypothesize that pathogenic variants impair cardiac calcium handling through excessive stabilization
of phospholamban oligomers. Aim 2b will test the specific hypothesis that a genetic variant linked to
heart failure changes phospholamban structural dynamics, increasing its structural disorder and
disrupting its inhibitory function.

Public health relevance
Project Narrative Relevance to Public Health: This research project is focused on micropeptides, small proteins that are important for controlling calcium levels in many different tissues in the body. In the heart, mis-regulation of calcium handling results in heart failure. Learning more about calcium handling may lead to future improvements in treatment of cardiac disease.